Mentoring Researchers in Aging in Vulnerable Populations

Project Summary
Dr. Kushel is a Professor in the Department of Medicine at the University of California, San Francisco (UCSF)
and Director of the UCSF Center for Vulnerable Populations (CVP). Trained as a general internist and health
services researcher, Dr. Kushel has mentored numerous individuals at various levels of training over the past
decade. She has done this while building a thriving research program focused on aging in vulnerable
populations, with a particular focus on the growing population of older adults experiencing homelessness. She
is currently funded by the NIA to fund the HOPE HOME Study, a cohort study of adults who are 50 and older
and homeless at study entry who her team has been following since enrollment in 2013-2014. During her initial
K24 award period, she received additional NIA funding, including an R01 to examine family relationships in
homeless older adults and an R34 to develop advance care planning materials for formerly homeless older
adults living in permanent supportive housing. She mentored 39 trainees, and published 45 papers, the vast
majority with mentees as first author. With the renewal of her K24 award, she will extend her research program
by adding a focus on sleep in older adults with an experience of homelessness, continue her efforts to mentor
junior investigators who study aging in vulnerable populations, and redouble her efforts to mentor trainees from
backgrounds underrepresented in research.
The overall aims of this K24 renewal proposal are: (1) Using HOPE HOME longitudinal data, examine the
association of individual (e.g. health status), behaviors (e.g. substance use), social (e.g. relationships) and
environmental (e.g. housing status and environment) with poor sleep in older homeless-experienced adults; (2)
Using qualitative methods, examine barriers and facilitators of sleep quality in older-homeless experienced
adults; (3) Using participatory design, develop a toolkit for homeless system and housing providers to promote
sleep in older homeless adults. The mentoring goals of this award include increasing Dr. Kushel’s expertise in
mentoring researchers from groups historically underrepresented in biomedical sciences.
The K24 would insure sufficient time to pursue this next phase in Dr. Kushel's research while protecting time to
devote to mentoring investigators in aging research for vulnerable populations. She has designed
complementary research and mentoring plans to create a synergistic effect of mentoring and research. The
proposed mentoring, research, and career development activities leverage existing infrastructure, resources,
and training initiatives provided by NIH including the UCSF Clinical and Translational Science Institute (CTSI),
SF Building Infrastructure Leading to Diversity (BUILD), MSTAR, the National Clinician Scholars Program and
several of UCSF’s T32 supported research fellowships including the Primary Care Research and Aging
Research Fellowships.

Public health relevance
PROJECT NARRATIVE This proposal will have public health importance because (1) it will increase mentoring of junior scientists interested in conducting patient-oriented research to improve care for vulnerable aging populations, and (2) it will inform interventions to improve sleep management in older homeless adults, in order to improve their quality of life and decrease worsening of geriatric conditions.